Structural basis of gating in the Ca2+ release-activated Ca2+ channels

PROJECT SUMMARY/ABSTRACT
Ca2+ release-activated Ca2+ (CRAC) channels are highly Ca2+-selective ion channels critical for regulating Ca2+
homeostasis and signal transduction in many cells. These channels are activated in response to the depletion
of endoplasmic reticulum (ER) Ca2+ stores and are expressed in both excitatory and non-excitatory cells.
Mutations in CRAC channel genes have been linked to severe immunodeficiencies, autoimmunity, and
debilitating myopathies, underscoring their physiological significance. CRAC channels are composed of two
proteins: Orai, the pore-forming protein in the plasma membrane, and STIM1, an ER-resident protein that
activates Orai upon Ca2+ store depletion. Despite significant progress, the structural mechanisms underlying Orai
activation remain poorly understood. A previous study revealed the structure and architecture of the wild-type,
closed state structure of the Drosophila melanogaster Orai (dOrai), showing a hexameric assembly with
concentric transmembrane domains that surround a central pore. However, the structural details of the open
state, including the conformation of pore-lining residues and the intracellular domains, remain unresolved. A 2020
cryoEM structure of a constituently open dOrai mutant offered preliminary insights into the open channel structure
but suffered from poor resolution and constraints imposed during the sample preparation. As a result,
fundamental questions about the structure and conformation of the channel in the open configuration persist. In
this proposal, I aim to address these gaps using structural techniques and functional approaches to study
the mechanism of CRAC channel activation and inhibition by CRAC channel antagonists. In Aim 1, I will
use cryoEM to analyze the structures of three well-studied dOrai open mutants which we hypothesize represent
different intermediate open states within the dOrai gating cycle. In Aim 2, I will study the effects of specific
inhibitors on the structure of dOrai and identify their binding sites. I will further extend the structural results by
functionally validating the binding sites through molecular dynamic simulations and electrophysiology studies.
Insights gained from these structures will advance our understanding of CRAC gating and aid future mechanism-
based drug discovery efforts targeting CRAC channels.

Public health relevance
PROJECT NARRATIVE CRAC channels control an essential Ca2+ entry pathway for many cell types and regulate important cellular processes, including gene expression and cytokine production. The goal of my project is to use structural and biophysical techniques to understand how CRAC channels open. Our work will significantly expand knowledge of CRAC channel physiology and aid future efforts to develop therapeutic to treat CRAC-associated channelopathies.